Decoding Spatial and Cellular Heterogeneity in Recurrence of WTC-Related Prostate Cancer

Project Summary
Prostate cancer rates are elevated among World Trade Center (WTC) responders, and some cases have
unfortunately recurred and progressed to aggressive disease. While our team has conducted one of the first
molecular profiling of WTC-related prostate tumors, current studies rely on bulk-tissue analyses, which overlook
the contributions of specific cell types and spatial interactions in the tumor microenvironment (TME). This
knowledge gap limits our ability to understand the mechanisms driving recurrence and impedes the development
of targeted therapies. To address this challenge, the objective of this application is to uncover the molecular and
cellular mechanisms driving prostate cancer recurrence in individuals exposed to World Trade Center (WTC)
toxins. By leveraging spatial transcriptomics and multi-omics analyses, we will identify key regulatory pathways
that differentiate recurrent tumors from those in remission in the spatial context of their TME. Our central
hypothesis is that prostate cancer recurrence is driven by spatially localized dysregulation of genetic pathways
and cellular interactions, e.g., DNA repair pathways and aberrant tumor-immune interactions specific to certain
regions within the TME. The research team with complementary expertise in cancer epidemiology, genome
technology, and cancer multi-omics will leverage several key innovations in this research project—including the
use of (i) the Mount Sinai WTC tumor biobank, (ii) cutting-edge spatial transcriptomic technologies, and (iii)
integrative computational pipeline for bulk/single-cell data—to resolve molecular drivers underlying the
recurrence of WTC-related prostate tumors at spatial and cellular definitions. The technical feasibility and
commitment of the research team are demonstrated by the strong preliminary data demonstrating our completion
of Visium HD spatial profilings on one recurrent vs. non-recurrent WTC-related prostate tumor, which will be
expanded to 20 primary WTC-related prostate tumors that recurred vs. achieved long-term remission in this
study. The two Aims are:
Aim 1. Identify Spatial TME Patterns associated with Recurrence in WTC-Related Prostate Tumors
Aim 2. Determine the Genomic and Epigenomic Regulatory Drivers of Recurrence in Prostate Cancer
This project is significant because it addresses a critical knowledge gap in understanding the recurrence of
prostate cancer, particularly in WTC responders. By identifying spatially localized molecular mechanisms driving
recurrence, the study has the potential to inform the development of targeted therapies, ultimately improving
outcomes for WTC-exposed prostate cancer patients and broader patient populations at risk for aggressive,
recurrent disease.

Public health relevance
Project Narrative The proposed research is relevant to public health because it will uncover how specific genes, cell types, and their spatial organization contribute to prostate cancer recurrence, particularly in individuals exposed to the World Trade Center (WTC) disaster. By generating a detailed map of the tumors that recurred vs. those that are successfully treated, this study will offer critical insights into why certain tumors relapse. These findings will guide the development of personalized treatment strategies aimed at preventing or managing aggressive prostate cancer, benefiting both WTC-exposed patients and the broader prostate cancer population.